STUDIES OF RARE TUMORS

We have employed case-control studies and studies that link cohort histories to cancer registry data (record linkage studies) to assess risk factors for rare tumors. A multicenter case-control study of cancers of the renal pelvis and ureter in the U.S. revealed no association with cumulative exposure to phenacetin, acetaminophen, or aspirin. A small elevation of risk was found in those with chronic hypertension, but it was not possible to disentangle the effects of hypertension from those of diuretic use. A large multicenter population-based case-control study of renal cell carcinoma in Australia, Denmark, Sweden, and the U.S. demonstrated increased risk with increased caloric intake and with consumption of fried meats. Consumption of fruits and vegetables was protective. We found that cigarette smoking increased the risk of adrenal cancer in a case-control study in which cases were identified through the National Death Index. This association was confirmed in a record linkage study of U.S. Veterans. The risk of non-Hodgkin's lymphoma was elevated among users of amphetamines, meprobamate, and lidocaine who were long-term members of a health maintenance organization (Kaiser). A case-control study of children with non-Hodgkin's lymphoma in Sweden, based on record linkage to the mother's delivery hospitalization, indicated an association with cesarean section and paracervical anesthesia, and children with this rare childhood cancer were more likely than controls to have had a metabolic or endocrine disorder. In collaboration with the Shanghai Cancer Institute, we initiated a population-based case-control study of biliary tract cancers in Shanghai, where the incidence of this disease is increasing.